PH I: IGIV CHROMATOGRAPHY, 10% VS IGIV SOLVENT DETERGENT TREATED 10%

This study is a Phase I study designed to test the safety of the 10% IVIG chromatography processed product. The blinded study is six month crossover with subjects receiving three months of Gamimune-N 10% then three months of the 10% chromatography preparation. Investigators are blinded to the order of administration. It is a multi-center study.